CORE A: Administrative Core

The overarching goal of the PROVIDENT consortium is to develop "plug-and-play" vaccine and
therapeutic antibody blueprints for three major groups of emerging enveloped RNA
viruses—nairoviruses, hantaviruses, and paramyxoviruses. PROVIDENT is organized into
four Research Projects, supported by three Research Cores and a Data Management Core. The
Administrative Core, Core A, will serve as the hub for PROVIDENT, providing governance,
personnel, and resources for all program management arms. Albert Einstein Colllege of Medicine
(Einstein) will serve as the lead institution and bear overall responsibility for PROVIDENT. To
achieve these goals and advance PROVIDENT’s strategic research plan, we will develop and
implement plans to: (1) organize, oversee, monitor, and report Center activities; (2) oversee and
facilitate data sharing with the ReVAMPP Center network and the public; (3) foster team
interaction and coordination; (4) communicate the Center's mission and activities to the scientific
community and the public; and (5) manage travel, conflict, change, risk, intellectual property,
human subjects and animals, resources, reagents, and regulatory challenges.

Public health relevance
Please see Overall for Project Narrative.